Cancer Prevention and Control Translational Research

DESCRIPTION (provided by applicant): The Cancer Prevention and Control (CPC) Program at the Arizona Cancer Center (AZCC) has developed a highly multi- and inter-disciplinary environment in which to train postdoctoral fellows. The primary purpose of this proposal is to continue this training program in which students can acquire the didactic and research experiences needed to successfully pursue a collaborative post-graduate career in cancer prevention and control. To achieve this goal, the proposed program will take advantage of a unique set of existing training opportunities resulting from the cooperative activities of the AZCC, the University of Arizona and our sister, minority university, Northern Arizona University. This training program will use the infrastructure provided by the R25T to continue to expand a successful fellowship program whose graduates have gone on to launch successful research careers in cancer prevention and control. The proposed program enables R25T fellows to obtain expertise in cancer prevention and control research through: 1) curriculum-based training; 2) strong AZCC CPC leadership; 3) specialized interdisciplinary research experiences in multiple disease sites; and 4) the NCI-funded faculty mentoring team. The research environment at the AZCC allows for a rich and unique training experience, which includes numerous opportunities in basic science, applied and translational research, an inter- and multi-disciplinary environment. The R25T Program Directors work closely with CPC faculty mentors to form a cohesive team for the individualized training of our postdoctoral fellows. The R25T Advisory Committee has the responsibility to ensure that fellows are selected carefully and monitored consistently throughout the fellowship. There is a need within the field of cancer prevention and control for scientists able to work and thrive in multi- and inter-disciplinary teams. Accordingly, the AZCC R25T training program exposes fellows to the breadth of disciplines within CPC while enabling them to focus on a primary research project from which to base future grant applications and publications.

Public health relevance
PUBLIC HEALTH RELEVANCE: The AZCC R25T Cancer Prevention and Control Training Program was first funded by the National Cancer Institute (NCI) in 1998. The program supports 4 postdoctoral fellows annually. The AZCC R25T Program was developed to train qualified candidates in a diverse experiential environment within the University of Arizona Cancer Prevention and Control Program (CPC) at the Arizona Cancer Center (AZCC). The Fellowship Program is directed by David S. Alberts, M.D., Iman Hakim M.D., Ph.D., and Elena Martinez, Ph.D. The broader goal of this R25T training program has been to create a rigorous multidisciplinary research training program that attracts highly qualified postdoctoral candidates and offers them the academic and research experience that supports a successful and productive career in cancer prevention and control. This training program has been designed to expose postdoctoral fellows to the broad array of scientific disciplines that contribute to the field of cancer prevention and control, including epidemiology, biostatistics, nutritional science, behavioral science, cancer biology, and clinical medicine, while fostering the fellows' excellence in their areas of primary research. R25T Fellows, selected from a range of primary disciplines relevant to cancer prevention and control (CPC), will be grounded in a multidisciplinary approach to cancer prevention and control through formal coursework, seminar series, workshops, conferences, interactions with mentors, and activities that are focused around the fellow's primary research project. The training program includes clear primary and secondary scientific and academic goals, constructive scientific criticism from top-level mentors, and support for presentation and publication of results. Mentoring is a key component of the fellowship program. The primary mentor is identified during the application process; primary mentors will have the lead mentoring role throughout the training of R25T fellows. All research, training, and career development activities are overseen by a mentoring team. R25T faculty mentors each have extensive training and research experience and offer fellows the necessary direction to successfully complete a mentored research project as well as to establish a career in cancer prevention and control. The primary mentors in the program all participate as principal investigators on a number of externally funded research projects. In addition to the mentoring team, the R25T program has an Advisory Committee that provides an additional level of mentoring and training oversight. This committee reviews the progress of each fellow and provides recommendations and guidance to further ensure the success of each fellow accepted into this program. To support the multidisciplinary training of young investigators, the training program requires that fellows engage in a primary research project and engage coursework in cancer prevention disciplines in which they may have had minimal exposure during their graduate careers. Fellows are also required to attend the CPC seminar series, which exposes them to a wide variety of research topics and disciplines in the field. Additionally, fellows are required to submit their work for presentation and publication, attend scientific and career development meetings, and develop a grant proposal for research funding. At completion of the program, we expect that all R25T fellows are prepared to proceed to successful and productive careers contributing to decreases in morbidity of and mortality from cancer. PUBLIC HEALTH RELEVANCE: The AZCC R25T Cancer Prevention and Control Training Program was first funded by the National Cancer Institute (NCI) in 1998. The program supports 4 postdoctoral fellows annually. The AZCC R25T Program was developed to train qualified candidates in a diverse experiential environment within the University of Arizona Cancer Prevention and Control Program (CPC) at the Arizona Cancer Center (AZCC). The Fellowship Program is directed by David S. Alberts, M.D., Iman Hakim M.D., Ph.D., and Elena Martinez, Ph.D. The broader goal of this R25T training program has been to create a rigorous multidisciplinary research training program that attracts highly qualified postdoctoral candidates and offers them the academic and research experience that supports a successful and productive career in cancer prevention and control. This training program has been designed to expose postdoctoral fellows to the broad array of scientific disciplines that contribute to the field of cancer prevention and control, including epidemiology, biostatistics, nutritional science, behavioral science, cancer biology, and clinical medicine, while fostering the fellows' excellence in their areas of primary research. R25T Fellows, selected from a range of primary disciplines relevant to cancer prevention and control (CPC), will be grounded in a multidisciplinary approach to cancer prevention and control through formal coursework, seminar series, workshops, conferences, interactions with mentors, and activities that are focused around the fellow's primary research project. The training program includes clear primary and secondary scientific and academic goals, constructive scientific criticism from top-level mentors, and support for presentation and publication of results. Mentoring is a key component of the fellowship program. The primary mentor is identified during the application process; primary mentors will have the lead mentoring role throughout the training of R25T fellows. All research, training, and career development activities are overseen by a mentoring team. R25T faculty mentors each have extensive training and research experience and offer fellows the necessary direction to successfully complete a mentored research project as well as to establish a career in cancer prevention and control. The primary mentors in the program all participate as principal investigators on a number of externally funded research projects. In addition to the mentoring team, the R25T program has an Advisory Committee that provides an additional level of mentoring and training oversight. This committee reviews the progress of each fellow and provides recommendations and guidance to further ensure the success of each fellow accepted into this program. To support the multidisciplinary training of young investigators, the training program requires that fellows engage in a primary research project and engage coursework in cancer prevention disciplines in which they may have had minimal exposure during their graduate careers. Fellows are also required to attend the CPC seminar series, which exposes them to a wide variety of research topics and disciplines in the field. Additionally, fellows are required to submit their work for presentation and publication, attend scientific and career development meetings, and develop a grant proposal for research funding. At completion of the program, we expect that all R25T fellows are prepared to proceed to successful and productive careers contributing to decreases in morbidity of and mortality from cancer. __SpecificAimsTextDelimiter__ 2. 0. Specific Aims The primary objective of this R25T Program is to train qualified candidates in a multidisciplinary environment focused on cancer prevention and control research. Our R25T postdoctoral fellows are trained to proceed to successful careers that will contribute to decreases in cancer morbidity and mortality. To achieve this objective, the following specific aims have been identified: " identify and recruit outstanding applicants from a range of disciplines relevant to cancer prevention and control; " provide cross-disciplinary opportunities to fellows via curriculum-based training and engagement in design and implementation of multidisciplinary research projects; " provide a structured training program that includes: 1) a core curriculum; 2) regular mentoring; 3) manuscript preparation and presentation skills; 4) grant and career development applications; 5) research projects; and 6) training in topics of special interest including leadership, ethics, statistics, human subjects requirements, and laboratory practice; and " further expand educational and collaborative links with major universities (e.g., Arizona State University, Northern Arizona University) that train large numbers of students from underrepresented populations in order to provide a direct link to career training of post-doctoral fellows and increase the number of researchers from underrepresented populations in the field of cancer prevention and control. To meet this aim, we will: a) utilize the Arizona Cancer Center's unique geographic location, which includes a local population base of 35.7% Latino and 2.5% Native American residents and a statewide base of 25.5% Latino and 5.8% Native American residents (US Census Bureau 2000), as compared to National Averages: 14.8% Latino, 0.7% Native American (US Census Bureau 2000); b) utilize collaborations with the College of Public Health's Arizona EXPORT (Excellence in Partnership for Community Outreach on Health Disparities and Training) Center project to identify public health graduates from underserved populations interested in post-doctoral training in cancer prevention and control; c) utilize our relationship with Northern Arizona University and the Native American Cancer Prevention Partnership (Northern Arizona University and Arizona Cancer Center U54 grant, co-PIs Drs. David Alberts, Francisco Garcia, Jesse Martinez, and Louise Canfield) to identify and increase Native American representation in this training program; d) utilize the formalized recruitment strategies for minority candidates with the Colleges of Public Health across the Arizona universities system; and e) draw upon our connections to on-campus multicultural centers and graduate students groups, such as the UA's Black Graduate Student Association (BGSA), the Latina/o Association of Graduate Students in Engineering and Science (LAGSES), and Native American Student Affairs (NASA). The broader goal of this R25T training program has been to create a rigorous multidisciplinary research training program that attracts highly qualified post-doctoral candidates and offers them the academic and research experience that supports a successful and productive career in cancer prevention and control. This training program has been designed to expose post-doctoral fellows to the broad array of scientific disciplines that contribute to the field of cancer prevention and control, including epidemiology, biostatistics, nutritional science, behavioral science, cancer biology, and clinical medicine, while fostering the fellows' excellence in their areas of primary research. This training is accomplished in a setting with clear roles for multiple mentors, where continuing education and skill development is encouraged and facilitated, and progress is monitored and evaluated regularly. At completion of the program, fellows are expected to: identify relevant and innovative hypotheses; secure funding to empirically test these hypotheses; publish peer-reviewed manuscripts; and complete a peer-reviewed research grant application or career development award application. This application will describe the inter- and multi-disciplinary scientific environment of the Cancer Prevention and Control (CPC) Program at the AZCC, the accomplishments and progress of this fellowship program over the first ten years of funding, and outlines the plans for the next funding period.